Summer Institute on Integrative Health Equity and Applied Research (IHEAR) - Administrative Supplement

Project Summary/Abstract
This proposal is for an administrative supplement for the five-year Integrative Health Equity and Applied
Research (IHEAR) summer research training program. The overarching goal of the IHEAR training program is
to build the capacity and diversity of the integrative medicine research workforce to advance health equity.
Through the current administrative supplement, we propose formally adding the following goal to the IHEAR
program: to support underrepresented minority learner success through multilevel mentoring support designed
to foster science identity. Towards this goal, we propose strengthening mentorship for diverse IHEAR fellows
by: (1) developing and disseminating tools to support faculty-fellow mentoring dyads in IHEAR; (2)
strengthening peer and near-peer support in the IHEAR program; and (3) building non-dyadic mentoring
structures for IHEAR fellows.

Public health relevance
Project Narrative Increasing the number of underrepresented learners is necessary but insufficient for building a diverse research workforce. The proposed supplement will strengthen the mentoring of diverse, predoctoral learners in integrative health equity and applied research. Program activities include multilevel mentoring support designed to foster science identity.